Defining Functional Dynamics of Multidomain Redox Enzymes

Project Summary
Multidomain proteins make up a large portion of the human proteome. Protein dynamics due to flexible linkers
connecting relatively rigid domains enable diverse biological functions, including electron transfer. Protein
electron transfer lies at the heart of life. Traditional biophysical approaches have generated valuable
"snapshots" of protein static states. However, multidomain proteins are best represented as a collection of
accessible, dynamic architectures. Both conformational dynamics and mechanisms of regulation remain largely
unclear, as the large size and conformational heterogeneity of multidomain, modular proteins pose significant
challenges to most individual structural dynamics techniques, necessitating integrative investigations.
The nitric oxide synthase (NOS) enzymes exemplify the complexity of modular proteins with elaborate interplay
of inter-domain conformational dynamics and regulatory mechanisms. NOSs are crucial for diverse signaling
processes and disease states, and understanding their regulation holds promise for therapeutic development.
The study of NOS has been quite difficult because its regulation involves not only dynamics but also partner
protein binding and post-translational modifications. The conformational control mechanism remains largely
uncharted. We have overcome several obstacles, demonstrating a strong record of prior accomplishment in
understanding large-scale conformational change. However, a comprehensive understanding will remain
incomplete without quantitative insights into more localized dynamics in the docked state. Additionally, despite
the abundant functional importance, the molecular mechanism of NOS regulation by phosphorylation remains
largely unclear. In this new synergistic effort, we will extend our current research on large-scale dynamics to
include the docked interdomain complex and explore more intricate systems in two research themes. The first
theme is on functional protein dynamics, emphasizing site-specific IR spectroscopic studies of the
conformations and dynamics of the docked states, as well as the mechanistic roles of phosphorylation and
intrinsically disordered regions in biasing the conformational landscape. Within the second theme of method
development, we will refine an approach combining quantitative cross-linking mass spectrometry and
AlphaFold prediction to probe the changes in structural dynamics of homodimeric NOS proteins in response to
external cues. This integrated approach draws on the unique synergistic expertise of our team. Our
interdisciplinary R35 research program is thus expected to accomplish an unprecedented understanding of
how regulatory interactions and modifications influence the conformational dynamics to fine-tune the protein
activity, with the potential to bolster advances in broad areas of biology and medicine. The proposed research
approach will also provide a blueprint for studying other complex, dynamic protein systems in which its function
is gated by conformational control of electron transfer. In addition, undergraduate, graduate, and post-doc
researchers will be broadly trained in multidisciplinary science, strengthening the nation’s scientific workforce.

Public health relevance
Project Narrative Proteins are often highly dynamic, and this flexibility is essential for function, but such motions often remain largely unclear. To advance a fundamental understanding of functional protein dynamics, we will investigate nitric oxide synthase (NOS), a family of paradigmatic multidomain proteins, using our integrative toolbox. The methodology developed here promises to be useful for studying the differences among the NOS isoforms, which in turn could be exploited to therapeutically target one NOS isoform over another.